The role of circulating meta-inflammatory monocytes in adolescent insulin resistance

ABSTRACT
Adults with obesity have increased myeloid inflammatory responses that associate with cardiovascular and
metabolic disease. There are several gaps, though, in our current understanding of metabolic inflammation
(meta-inflammation) including our understanding of initiating changes in myelopoiesis and regulated changes
in myeloid cells. It is clear that some individuals develop a meta-inflammatory response placing them at higher
risk for metabolic impairment while others are protected. While it is clinically important to identify adolescents
at risk for future disease, we do not understand how to use meta-inflammatory markers to assess disease risk.
Our previous human and mouse studies demonstrate that individuals who expand inflammatory monocytes in
response to obesogenic diets are at greatest risk for metabolic disease. Based on the ability of these
monocytes to generate an inflammatory response, traffic to tissues and differentiate into inflammatory tissue
macrophages promoting insulin resistance, we are terming them meta-inflammatory monocytes (MiMo). Given
that animal models and clinical studies have demonstrated that myeloid inflammation with circulating cytokines,
enhanced circulating myeloid cells and tissue inflammation are linked with insulin resistance it is critical to
understand if these same mechanisms exist in adolescents and can differentiate who is at risk for future
metabolic disease. This proposal is based on the scientific premise that a diet high in saturated fatty acids
(SFA) leads to myeloid leukocyte activation with expansion of myeloid progenitors, Ly6chi blood monocytes,
and pro-inflammatory tissue macrophages leading to tissue dysfunction in animal studies. We propose the
central hypothesis that adolescents at risk for metabolic disease have an increase in MiMos and enhanced
MiMo recruitment, cytokine secretion and macrophage polarization leading to insulin resistance. We will
evaluate this hypothesis in three aims: Aim 1) To define the monocyte transcriptomic signatures associated
with metabolic disease in adolescents. Aim 2) To determine high risk and low risk monocyte phenotypes
produced in adolescents with metabolic impairment. Aim 3) To assess meta-inflammatory monocyte activation
and metabolism in response to dietary fatty acid stimulation. This proposal is innovative in the modeling and
translational approach which is of high clinical significance. While the role of inflammation and metabolic
disease has been studied over the last few decades little is known about this association in adolescents. This
project will close the critical gap in translating pre-clinical studies on meta-inflammatory monocytes (MiMos) to
adolescents. It will also investigate the mechanisms of disease risk through identification of detrimental
monocyte phenotypes and the role of dietary fats in driving MiMo activation. These findings will lead to both
biomarkers for prediction and pathways for intervention in pediatric metabolic disease.

Public health relevance
PROJECT NARRATIVE Impaired metabolism is known to be strongly associated with a metabolically induced inflammation with an increase in white blood cells called myeloid cells (monocytes/macrophages) in animal models and studies in adults. However, risk for these diseases and inflammatory responses to obesity are not uniform and further identification of who is at risk could potentially prevent disease manifestation. This proposal seeks to evaluate if circulating monocyte gene expression and phenotype can characterize adolescents with obesity with a risk for meta-inflammation and if nutritional fatty acids can modify this risk.